Core B Ocular Imaging Core

Abstract
Ocular Imaging Core
The Ocular Imaging Core will provide a variety of imaging modalities to the investigators involved in this P30 Cole Eye
Vision Research Core. The module includes live animal (in vivo) imaging with slit lamp and fundus photography,
scanning laser ophthalmoscopy (SLO) and optical coherence tomography (OCT). It also supports tissue and cellular
imaging (ex vivo) support, providing training and assistance with routine and specialized tissue fixation techniques,
paraffin and plastic tissue embedding, sectioning (paraffin and Cryo) and staining for immunohistochemistry.
Microscope imaging techniques include bright field, dark field, differential interference contrast (DIC), fluorescence,
and confocal microscopy . It also provides help and advice with the morphometric analysis of generated images. Access
to this core module will support NEI R01 funded investigators, help newly recruited investigators obtain data for NEI
R01 grant submissions, foster collaborative interactions between RO1-funded investigators and newly recruited
investigators, attract investigators from other departments to research on the visual system and be a valuable
departmental resource in attracting additional vision scientists to our program as we expand our research faculty.